Neocortical microarchitecture of executive function using large-scale intracranial electrophysiology

PROJECT SUMMARY
Advancing our understanding of the neural basis of human cognition is limited due to the rarity of intracranial
recordings in humans, and the inherent inadequacy of animal models. Additionally, studying something as
complex and flexible as executive function will likely require recording from hundreds of neurons
simultaneously, a scenario not currently possible in humans with the existing recording technology. Here we
propose to use a new probe, the Neuropixels probe, with 960 possible recording electrodes on a single shank,
to study human executive function. Placing these Neuropixels probes in the dorsolateral prefrontal cortex
during awake deep brain stimulation recordings, we will assess the neural population activity during an
executive function task that employs feature selection, conflict processing, and decisions (Aims 1 and 2).
Making use of the unique recording structure of the probe, with electrodes placed regularly along the shank,
we will evaluate the local topography, expecting cortical layers to stratify neural responses to task-conditions
(Aim 1). We will also evaluate the neural population response to task conditions, hypothesizing that the neural
dimensions and geometry exhibit features that explain the flexibility so crucial to executive function (Aim 2).
This study will establish the neural underpinnings of human executive function.

Public health relevance
PROJECT NARRATIVE Our understanding of the neural basis of human cognitive abilities has been limited by opportunities and methods to record from populations of single neurons in the human prefrontal cortex. This work leverages recent advances in neurotechnology and opportunities to record from awake humans to study how populations of neurons in prefrontal cortex mediate human cognitive function. Using a unique neural probe that can record hundreds of neurons from a single shank, we will study executive function during awake deep brain stimulation surgeries.